Kidney Injury Molecule-1 in Epithelial Repair

Project Summary/ Abstract
Kidney Injury Molecule-1 (KIM-1) is the most upregulated protein in proximal tubular epithelial cells in various
states characterized by epithelial cell dedifferentiation: ischemia, toxic renal injury, and renal cell carcinoma.
We have cloned, generated cells and animals expressing wild-type and mutant KIM-1, and created monoclonal
and polyclonal antibodies to, human, mouse, rat, pig, dog, and zebrafish KIM-1. We have reported that the
KIM-1 ectodomain is cleaved into the blood and urine of subjects with acute (AKI) and chronic (CKD) kidney
injury and is a sensitive and specific kidney injury biomarker to detect kidney injury and predict progression of
CKD. KIM-1 has been qualified by the FDA for preclinical and clinical use in kidney safety studies. We have
discovered that KIM-1 transforms kidney epithelial cells into semiprofessional phagocytes making it the
first nonmyeloid phosphatidylserine receptor. We have described a novel phagocytosis pathway that links
autophagy to KIM-1-mediated phagosome maturation and MHC restricted antigen presentation in epithelial
cells. We have shown that KIM-1 expression in early AKI is adaptive, but chronic expression leads to
CKD with severe fibrosis, secondary hypertension, and cardiac hypertrophy. A mouse lacking the
extracellular mucin domain, important for phagocytosis, is protected against development of fibrosis. We
have found that KIM-1 mediates uptake of palmitate-bound albumin and recently found an inhibitor of KIM-1-
mediated phagocytosis by screening a small molecule library. The inhibitor reduces cell lipotoxicity and
fibrosis in a novel mouse model of diabetic kidney disease. The current competing renewal application builds
upon and extends our prior findings. Our goal is to further characterize KIM-1-mediated uptake of fatty acid
bound albumin (FA-Albumin), and the implications of this uptake for cellular injury and maladaptive repair,
including cell senescence leading to profibrotic and proinflammatory responses that ultimately lead to
progressive CKD. KIM-1 may be a drug target to prevent and treat CKD. We hypothesize that persistent
KIM-1-mediated endocytosis of FA-Albumin and subsequent signaling leads to toxicity. FA-Albumin
uptake leads to a mitochondrial dysfunction, DNA damage response (DDR), G2/M arrest, mTOR
signaling, TASCC formation, and a prosecretory fibrotic phenotype. In addition KIM-1-FA-Albumin
uptake leads to chronic tissue inflammation in part due to tertiary
lymphoid tissue development through LTaβ/LTβR signaling. In Specific Aim 1 we will characterize
binding of KIM-1 to FA-Albumin and determine the architecture, structural dynamics and molecular basis for
FA-Albumin binding to KIM-1. In Specific Aim 2 we will characterize the intracellular consequences of KIM-1
mediated FA-Albumin endocytosis, particularly on mitochondrial function, DNA damage, the DDR, cell cycle
arrest and the profibrotic secretome. In Specific Aim 3 we will evaluate the role of KIM-1 mediated FA-
Albumin uptake and DDR in LTaβ/LTβR signaling leading to tertiary lymphoid tissue (TLT) formation
with consequent pro-inflammatory consequences in animal models of AKI to CKD transition.

Public health relevance
Project Narrative We have discovered Kidney Injury Molecule-1 (KIM-1), a protein that kidney proximal tubule cells express when they are injured. If KIM-1 is expressed over longer periods of time it leads to progressive kidney failure. KIM-1 acts to increase re-uptake of many noxious molecules that the kidney filters including albumin with bound fatty acids. Our goal is to understand how this uptake leads to organ failure so that we can develop strategies to prevent progression of chronic kidney disease, reducing side effects such as cardiovascular disease and the need for hemodialysis or transplantation.